Integrin mediated regulation of lymphatics during aging and neurodegeneration

PROJECT SUMMARY/ABSTRACT
This project aims at understanding how the integrin CD49a participates in age-associated loss of meningeal
lymphatic function and in the development of cognitive decline and neurodegenerative diseases, particularly
Alzheimer's disease. Our previous studies demonstrated that aging correlated with both morphological and
functional loss of meningeal lymphatic function, and that restoring meningeal lymphatic function in aging mice
improved cognitive decline and limited physiopathology in a mouse model of Alzheimer's disease. Transcriptomic
analysis of aged lymphatic endothelial cells revealed that interactions with the extracellular matrix and the
microenvironment may represent major factors in their age-associated loss of function. However, the molecular
mechanisms controlling the age-associated degeneration of the meningeal lymphatic remains unknown.
Our preliminary data demonstrate that the integrin CD49a is expressed by lymphatic endothelial cells and
increases with aging. We generated a mouse where CD49a is deleted from lymphatic endothelial cells (LEC) (using
the Prox1creERT2 mice), and found that loss of CD49a by LEC improves their function. Furthermore, genome-wide
associated studies have identified CD49a as an associated gene with Alzheimer's disease. We found that global
CD49a-deficient mice have reduced amyloidosis pathology when crossed with a mouse model of Alzheimer's
disease. We therefore hypothesize that this age-associated increase in CD49a expression participates in their age-
associated functional decline, participates in the development of cognitive decline, and promotes the accumulation
of amyloid aggregates in Alzheimer's disease.
Guided by our preliminary data, we propose to address our hypothesis using the following aims:
Aim 1: Determine the effects of CD49a in meningeal lymphatic function during aging.
Aim 2: Delineate how CD49a expression by LEC contributes to age-associated brain dysfunction.
Collectively, our propose studies will have a significant impact by: a) revealing a molecular pathway
regulating age-associated meningeal lymphatic function, b) highlighting the importance of meningeal lymphatic
function in the maintenance of brain health during aging, and c) providing evidence for the therapeutic potential of
CD49a to manipulate meningeal lymphatic function in aging and neurodegeneration.

Public health relevance
PROJECT NARRATIVE Aging is the primary risk factor for most neurodegenerative disorders, including Parkinson's disease and Alzheimer's disease (AD), and recently the meningeal lymphatic system appeared as a central player regulating cognitive decline with age and contributes to development of AD. Our goal is to investigate how age- associated changes in meningeal lymphatic interactions with their local microenvironment, notably through integrin signaling, participate in their age-associated degeneration, cognitive decline, and favors the development of AD. Successful completion of this proposal will identify a new therapeutic target to limit the effect of aging on the central nervous system, potentially limiting development of neurodegenerative disorders.